MECHANISMS LEADING TO ADVERSE BIRTH OUTCOMES IN SOUTH AFRICAN HIV-INFECTED WOMEN

Pre-term birth (PTB) is a major cause of neonatal mortality worldwide, associated with high morbidity due to
infectious and other complications. Identifying risk factors for adverse birth outcomes, as well as the likely
causes, will facilitate prevention measures to mitigate these outcomes. Sub-Saharan Africa (SSA) has the
highest burden of these adverse pregnancy outcomes, and also bears the brunt of the global HIV epidemic,
with over 33 million people living with HIV. Untreated maternal HIV infection has been shown to be associated
with spontaneous PTB in some but not all studies. Antiretroviral (ARV) drug treatment during pregnancy
dramatically reduces perinatal HIV transmission but has also been linked to adverse birth outcomes. Here, we
will utilize our completed and ongoing cohorts of pregnant women in Cape Town, South Africa, and build on
our previous phase 1 NIH-SAMRC funding (R21 HD083344), to study the impact of HIV/ARV exposure on
female genital tract microbiology and metabolome and the relationship with placental immune pathways that
impact infant health: prematurity and post-partum vaccine immunogenicity. The specific aims are 1) To identify
vaginal microbial and metabolic markers for adverse birth outcomes in HIV-infected women. Here, we
hypothesis that PTB is associated with specific vaginal microbial communities leading to alterations in
metabolic pathways that can result in cell stress and subsequent placental inflammation. We will use 16S
rRNA sequencing and unbiased mass spectrometry to measure vaginal microflora and metabolites during
gestation. 2) To interrogate immune cell subsets and gene expression pathways in placental decidual and
villous tissue which lead to PTB in HIV-infected pregnancies. We hypothesize that placental T cells are
skewed away from regulatory towards inflammatory and activated states through HIV/ARV exposure, leading
to increased risk of preterm labor. We will use a combination of multiparameter flow cytometry, imaging and
RNAseq to characterize T cell populations, their tissue location and function. Placentas from HIV-uninfected
women will be used as controls. 3) To identify decidual immune cells and gene expression pathways that
influence infant cellular immunity. We hypothesize that inflammatory conditions at the fetal-maternal interface
contribute to the development of compromised vaccine-specific immunity post-partum. We will measure infant
BCG T cell responses in the first two months of life and relate this to placental cell phenotype, function and
gene expression in mother-infant pairs. Identifying risk factors for adverse birth outcomes, as well as the likely
causes, will facilitate prevention measures to mitigate these outcomes.
!
!

Public health relevance
NARRATIVE HIV-infected, antiretroviral-treated women are more likely to have adverse birth outcomes, and their infants have altered immunity even in the absence of HIV-infection. Here, we will investigate the impact of maternal vaginal microbiome and metabolites during pregnancy and immune regulation and inflammation in placentas at delivery on preterm birth risk in HIV-infected women. We will utilize a long-standing cohort study population in Cape Town South Africa to determine which immune events at the fetal-maternal interface contribute to spontaneous preterm birth in HIV infection, and whether these relate to impaired newborn immunity.